Machine Learning-Based Adaptation of Data Sampling and Reconstruction for Efficient Dynamic MRI

ABSTRACT
Magnetic resonance imaging (MRI) is essential for the detection and diagnosis of diseases. Clinical MRI scanners use
ﬁxed sequential data sampling patterns with long acquisition times, and employ nonadaptive reconstruction algorithms
to generate images. The acquisitions are not usually tailored for the speciﬁc clinical task and patient characteristics,
leading to sub-optimal images; they are often low-resolution, blurry, or contain errors that can reduce their diagnostic
efﬁcacy. Dynamic imaging applications, in which many images must be captured quickly to depict the motion of organs
such as the heart, tend to suffer the most from these ill-effects. We propose to replace the conventional dynamic MRI
acquisitions with a machine learning-based acquisition system, where the data sampling is efﬁciently optimized together
with the reconstruction approach and task prediction, for optimized image quality and clinical task performance. First,
we will explore and compare different ways of learning fast sampling of MRI frames to optimize image reconstruction
quality metrics using large public data sets and current sophisticated (iterative) reconstruction algorithms. We will as-
certain the sampling learning strategies that achieve the best image reconstruction quality at high data undersampling
factors. Second, we will further extend machine learning throughout the MRI pipeline and develop approaches for joint
adaptation of the data acquisition and image reconstruction and ﬁnally the task (e.g., quantiﬁcation task) predictor as
well. A key approach will use highly undersampled initial acquisitions (of current frame) and/or past (frame) data as input
to the learned acquisition model to rapidly predict a patient- and frame-adaptive optimized sampling pattern. Then the
samples from the scanner will be used to rapidly produce machine-learned reconstructions followed by task predictions.
Particularly, for dynamic MRI, the temporal information from preceding images (frames) will be effectively incorporated
and exploited in the proposed machine-learned models to drive efﬁcient on-the-ﬂy adaptive acquisitions and reconstruc-
tions. We propose the mathematical formulations and algorithmic framework to accomplish these goals. The developed
learning-based methods will be comprehensively evaluated and cross-compared in terms of image quality metrics (e.g.,
root mean squared error) and dynamic cardiac MRI task performance (ejection fraction estimation) at several undersam-
pling or acceleration rates, and benchmarked using existing data sets as well as using newly collected cardiac MRI data.
The development of smart imaging technologies that infuse learning across the imaging pipeline could enable rapid and
effective task-driven adaptive imaging for dynamic cardiac MRI and related applications. Such a machine-learning MRI
system could potentially improve clinical diagnosis and treatment, by helping enable the imaging system and acquisition
to adapt in real-time to optimally detect and image various features at high resolution. Our goal in this project is to
conduct the initial comprehensive studies to determine and analyze the potential, robustness, and algorithm behavior of
the proposed machine learning dynamic MRI framework and techniques.

Public health relevance
Public Health Relevance Statement Magnetic resonance imaging (MRI) is a noninvasive imaging technique that has contributed signiﬁcantly to improving our understanding of body structure and function, and serves as an important tool in clinical diagnosis and treatment. However, the data in MRI are collected or acquired sequentially, which leads to slow scans, and also limits image quality, resolution, and clinical performance, especially in applications such as cardiac imaging. This project will help develop improved machine learning-based dynamic MRI systems that will adapt the data collection, image reconstruction, and task prediction on the ﬂy for rapid imaging, and for optimized image quality, resolution, and performance in clinical practice.